ESOPHAGEAL MOTOR FUNCTION IN HEALTH AND DISEASE

Continuous monitoring of esophageal motor function, lower esophageal sphincter pressure and esophageal pH are performed in subjects with sporadic episodes of gastroesophageal reflux and compared to normal volunteers. The importance of swallowed saliva in esophageal acid clearance is also examined. Lower esophageal sphincter relaxation and abnormal esophageal reflus in patients with gastroesophageal reflux and other disorders are examined.